Mechanisms of microcystin-induced hepatocellular carcinoma in nonalcoholic steatohepatitis

Microcystin-LR (MCLR) is the most potent and abundant cyanotoxin produced by freshwater blue-green algae.
MCLR exposure is associated with nonalcoholic fatty liver disease (NAFLD) and hepatocellular carcinoma
(HCC). NAFLD has quickly risen to become the most common chronic liver disease in many countries, and HCC
is the most common type of primary liver cancer. My K99/R00 data indicate MCLR drives progression of
nonalcoholic steatohepatitis (NASH), an advanced form of NAFLD, to a more severe burnt out phenotype
(increased fibrosis and reduced steatosis). The burnt out stage is an important pathogenic step towards
irreversible cirrhosis and HCC. Preliminary data in Sprague Dawley rats indicate that MCLR-elicited burnt out
NASH persists 4 weeks after MCLR exposure, in contrast to the control diet group that returned to a baseline
phenotype. In addition, MCLR persistently dysregulated matrisome genes (related to fibrosis) and
carcinogenesis genes (de-differentiation/stem cell markers) in NASH. Based on these data we hypothesize
MCLR-mediated fibrotic and carcinogenic reprogramming of the liver is enhanced in NASH and promotes the
development of cirrhosis and HCC. This hypothesis will be tested in two aims. Aim 1 will determine the role of
the protein phosphatase 2A (PP2A)-associated pathways in MCLR-mediated stellate cell activation and
hepatocyte de-differentiation. Considering the liver is the primary target for MCLR, there is surprising paucity of
research investigating these pathways and none have examined the cell type specific effects of PP2A. STUDY
1.1 will define the contribution of specific PP2A-associated pathways responsible for MCLR-elicited hepatocyte
and stellate effects using MCLR and PP2 modulators in human HepaRG hepatocytes and human LX2 stellate
cells co-cultured as 3D spheroids in static culture or microfluidics. STUDY 1.2 will test the hypothesis that
hepatocytes are the primary MCLR target and stellate cells are activated by hepatocyte damage using HepaRG
and LX2 cells cultured individually or in combination in transwell plates. STUDY 1.3 will define the effects of PP2A-
pathway modulators on MCLR- and NASH diet-elicited liver pathology in rats fed either a control or a NASH diet.
Aim 2 will determine the mechanisms and long-term effects of MCLR-elicited fibrotic and carcinogenic
reprogramming on cirrhosis and HCC development in healthy versus NASH. STUDY 2.1 will mimic important
aspects of the original MCLR tolerable daily intake study including the dose (40 µg/kg), interval (daily), and
duration (3 months) in the context of a tumor initiator (diethylnitrosamine) and a NASH diet. These mechanistic
studies will be complemented with phosphoproteomics and single nuclei transcriptomics analyses, potentially
providing druggable targets. This research will have sustained impact because it will be the first to
comprehensively assess MCLR-elicited cirrhosis and HCC in pre-existing liver disease. By mimicking the TDI
study, this research may indicate a lower TDI is required for people with pre-existing liver disease.

Public health relevance
Exposure to microcystin toxins produced by freshwater algae is associated with liver cancer. Nonalcoholic fatty liver disease is a common chronic disease that can progress to cirrhosis and liver cancer after exposure to environmental compounds. This research will determine the role of microcystin in driving progression of nonalcoholic fatty liver disease to cirrhosis and liver cancer.